B Cells at the Intersection of Innate and Adaptive Immunity

? DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled B Cells at the Intersection of Innate and Adaptive Immunity, organized by Mikael C. I. Karlsson, Claudia Mauri, Eric Meffre and Andrea Cerutti. The meeting will be held in Stockholm, Sweden from May 29 - June 2, 2016. In the last few years, the role of B cells in the innate immune response and effector functions beyond antibody production has started to be appreciated. This meeting puts emphasis on these newly discovered roles of B cells and discusses novel concepts in B cell biology that will open new venues to design B cell-directed treatments. It will thus highlight the function of B cells as general responders and regulators of inflammation and contrast this to their function as antibody producers. This meeting's focus on the roles of this cell type beyond antibody production lies well in line with the interests of NIAI as this function has a broad impact on both inflammatory diseases and infection. The 2016 Keystone Symposia meeting on B Cells at the Intersection of Innate and Adaptive Immunity will discuss novel concepts in B cell biology and how to move forward putting this cell lineage in the center as a regulator of inflammation.

Public health relevance
PUBLIC HEALTH RELEVANCE: In recent years our knowledge in B cell biology has moved forward. In particular, we now know more about how and where this cell type develops, the genetic and cell biology events leading to production of antibodies, and how B cells in addition to producing antibody modulate immune responses. Although treatments targeting B cells have shown great efficacy in cancer and autoimmune diseases there is an unmet need for further understanding of how pathological B cell activation contributes to disease in order to steer the response away from self-reactivity that cause disease. The Keystone Symposia meeting on B Cells at the Intersection of Innate and Adaptive Immunity will focus not only on how antibodies are being made but rather broaden the scope on B cell activation and effector functions.